REpeated ASseSsmEnt of SurvivorS in ICH (REASSESS ICH)

Project Summary / Abstract
Purpose: The REpeated ASSEssment of SurvivorS in ICH study will conduct long-term cognitive, functional,
and neuropsychiatric performance assessments to determine if evacuation of spontaneous intracerebral
hemorrhage (ICH) reduces the risk of later cognitive decline in the ageing brain. This study will compare rates
of cognitive decline under two treatment strategies for intracerebral hemorrhage: the use of minimally invasive
surgery with two similar techniques as performed in the recently completed MISTIE III and ENRICH trials, and
the current standard of care using data from both controls in MISTIE III and ENRICH and comparative data
from The Ethnic/Racial Variations of ICH (ERICH) study (U-01-NS067963) extended into the ERICH-
Longitudinal study (R01-NS093870) which followed over 900 of the cases with serial cognitive examinations.
Rationale: Intracerebral hemorrhage has the highest disability rate among stroke survivors. ICH survivors are
at particularly high risk for progressive cognitive impairment which is strongly associated with greater
hematoma volume, but also with cerebral amyloid angiopathy. Compared with standard of care, minimally
invasive surgery with effective hematoma volume reduction may improve long-term functional outcomes while
also reducing mortality. As such, reducing hematoma volume after ICH may reduce the risk of post ICH
cognitive decline.
Design: REASSESS ICH is a longitudinal structured serial telephone interview follow-up plus one-time in-
person visit of an anticipated 359 ICH survivors enrolled in MISTIE III (2013-2017) or ENRICH (2018-2022).
Cognitive and functional outcome data will be compared with up to 900 patients enrolled in ERICH-L, to
determine if surgical ICH reduction leads to reduced risk of progressive cognitive decline.
Primary Aim 1: To determine if surgical clot reduction after ICH reduces the risk of progressive cognitive
decline. Hypothesis: The final residual volume of ICH will correlate with risk of cognitive decline after controlling
for age, sex, initial volume of ICH, leukoaraiosis, APOE genotype, and hypertension treatment among operated
and non-operated survivors of MISTIE III/ENRICH and survivors of ERICH, and effective clot reduction (<20
mL end of treatment volume), will be associated with lower risk of cognitive decline compared to non-operated
patients.
Primary Aim 2: To determine if there is a long-term benefit in survival and functional outcome from minimally
invasive surgery and the interaction with cognitive decline. Hypothesis: Effective clot reduction will be
associated with a decreased risk of death/major disability compared to non-operated patients.
Exploratory Aim 3: To determine if inflammatory gene pathway expression predicts risk of cognitive decline.
Hypothesis: Chronic brain inflammation contributes to progressive cognitive impairment post ICH. Our
preliminary data identifies that inflammation appears to occur chronically after ICH; not just acutely. When
testing a wide variety of gene expression changes, the context of which pathway is involved is critical to
provide context. We will evaluate whether inflammatory pathways in particular predict patients with cognitive
impairment independent of gene risk scores for dementia and surgical status.

Public health relevance
PROJECT NARRATIVE Intracerebral hemorrhage is complex, has long-term significant cognitive and functional impairment, and has no proven treatment, resulting in a disproportionate disability rate and lifetime cost among stroke survivors. By employing novel cognitive outcomes methodology to study long-term outcomes in ICH with enhanced retention, we may accelerate understanding of the causes of cognitive impairment after ICH. In the REpeated ASSEssment of SurvivorS in IntraCerebral Hemorrhage study (REASSESS ICH), we will determine whether reduction of ICH volume with minimally invasive surgery is a critical target to reducing the risk of progressive cognitive decline, targets for residual hematoma volume and whether inflammatory pathways in particular predict patients with cognitive impairment independent of gene risk scores for dementia and surgical status.